SID Retreat

The mission of the Society for Investigative Dermatology (SID) is ‘To advance and promote the sciences
relevant to skin health and disease through education, advocacy, and scholarly exchange of scientific
information.’ Part of this mission is to ensure there is an adequate pipeline of educators and researchers
to foster the next generation. Over the past few decades, there is a notable shortage of Academic
Dermatologists in the United States. Among the 127 ACGME accredited Dermatology residency
programs in the US, a relatively small percentage of graduating residents indicate an interest in
academic medicine and teaching the next generation. Members of the SID represent a significant
percentage of U.S. dermatology faculty. The SID is uniquely suited to address the problem given its
access to both faculty and resident physicians. The SID mission and that of the National Institute for
Arthritis and Musculoskeletal and Skin Diseases (NIAMS) are largely overlapping. Both are committed to
supporting skin disease research and training basic and clinical investigators. The two organizations
have a vested interest maintaining a pipeline of dermatology educators and researchers. To leverage
potential synergy in the missions of the SID and NIAMS, the SID Retreat was developed. The SID
Retreat is an annual conference presented by the SID for a select group of first, and second-year
dermatology residents and PhD-trained post-doctoral fellows who have expressed an interest in a career
in academics. The program tests the hypothesis that early and sustained exposure to like-minded
residents, post-docs and seasoned faculty will have a positive effect on a decision to enter academia. To
achieve our goals, we will continue to expand upon the format utilized over the past 20 years, which
included discussions of grant writing, finding mentors, negotiating a job (and protected time), economics,
work-life balance, developing an interest area, integrating academics into dermatologic specialties,
finding funding, and how to form meaningful collaborative liaisons between MD- and PhD-trained
scientists, educators and clinicians. New recruitment strategies will be used in this iteration of the SID
Retreat to enhance and grow our Diversity and Inclusion (D&I) initiatives, to increase the URM pipeline,
to retain people of color, and to synergize with existing D&I initiatives ongoing within in the SID. This
retreat provides scientific and educational opportunities for future leaders in dermatology and supports
the core values of the SID. Outcome analyses measured by retention in academia supports the SID
Retreat as effective at promoting increases in academic retention.

Public health relevance
The Society for Investigative Dermatology (SID) Retreat is an annual conference specifically designed to increase the number of dermatology residents and PhD trained skin scientists that enter academia. The SID Retreat provides formal and informal mentoring and panel discussions focused on career development, work-life balance, career paths, obtaining research funding, and provides useful information about circumventing barriers to entry into academia and insight into grant funding opportunities and the publication process. The ability to increase the pipeline of multidisciplinary educators and scientists focused on skin biology, wellness and disease supports the mission of the SID to advance sciences relevant to skin disease through education, advocacy and scholarly exchange of scientific information and will help identify, retain, and support future generations of dermatologists and investigative skin scientists.